The Mechanism of Arenavirus Entry into Cells

Pathogenic Old and New World arenaviruses cause severe hemorrhagic fever in humans. There are currently
no approved vaccines or drugs to battle arenavirus infection. Despite intensive studies, arenavirus entry
pathways into host cells and the mechanism of arenavirus glycoprotein (GP) mediated virus-cell fusion are not
well understood. Old World and New World arenaviruses use distinct cellular receptors and poorly characterized
endocytic pathways to enter and infect cells. Based on our preliminary data and published work, we propose a
novel overarching hypothesis that Old and New World arenaviruses use common post-uptake pathways to enter
a subset of late endosomes that contain a specific lipid cofactor, LBPA, but lack the host restriction factor IFITM3.
We found that fusion of diverse arenaviruses is promoted by LBPA and that the Lassa virus bypasses
endosomes enriched in IFITM3, thereby escaping restriction. We also found that GP-mediated fusion requires
thiol-disulfide interchange within this glycoprotein and obtained evidence that GP mediates arenavirus
membrane permeabilization prior to fusion with acidic endosomes, which we hypothesized promotes subsequent
virus uncoating. The following four Specific Aims will test the above hypotheses. (1) Delineate the entry pathways
of representative Old and New World arenaviruses, using real-time single pseudovirus imaging. (2) Define the
role of LBPA in arenavirus fusion and identify the GP lipid-interacting motif. (3) Examine the requirement for GP
thiol-disulfide interchange in arenavirus fusion. (4) Elucidate a role of GP-mediated virus membrane
permeabilization in uncoating. Successful completion of the proposed experiments will provide important
fundamental insights into the mechanism of arenavirus entry/fusion and identify new therapeutic targets for
intervention.

Public health relevance
Pathogenic arenaviruses, such as Lassa and Junin viruses, cause severe hemorrhagic fever in humans. No specific antivirals or an FDA-approved vaccine are available against these pathogens. To inform new therapeutic strategies, we propose to delineate the entry pathways of Old and New World arenaviruses into cells and identify key intermediate steps of the viral fusion process that initiates infection.